Biochemical Mechanism of Beta-Cell Destruction

Project Summary/Abstract
Autoimmune diabetes is characterized by an inflammatory reaction in and around pancreatic islets that is
followed by the selective destruction of insulin producing β-cells. The conventional wisdom suggests that
cytokines, released during islet inflammation, contribute to the development of autoimmune diabetes by directly
impairing b-cell function and reducing β-cell mass. In support of this hypothesis, treatment of islets with IL-1
alone, or in combination with IFN-g and/or TNF, results in an inhibition of insulin secretion and oxidative
metabolism, induction of DNA damage and a loss of β-cell viability that is mediated by iNOS expression and the
production of nitric oxide by β-cells. For over 30 years there has been an intense focus on determining the
mechanisms by which IL-1 damages β-cells, yet there is little direct evidence supporting a role for IL-1 in the
development of autoimmune diabetes. Pancreatic β-cells are terminally differentiated with a limited capacity for
self-renewal yet produce a hormone (insulin) that is essential for organismal survival. IL-1 is a pyrogenic cytokine
that is well known to induce fever and inflammation during infection and injury. If the β-cell response to IL-1 were
solely damaging, then most individuals would be highly susceptible to diabetes, as 90 % of the volume of blood
that enters the pancreas travels through islets (which represents 1% of the wet weight of the pancreas) such that
β-cells would be bathed in IL-1 during infection and injury. This application will test the hypothesis that there is a
physiological role for IL-1 signaling in β-cells that is designed to protect these cells from impending danger or
insult. By understanding the delicate balance between the damaging and protective actions of cytokines on β-
cell function and survival, we hope to elucidate the physiological and pathophysiological roles of IL-1 signaling
in β-cells. There are thee aims that will test the hypotheses that: 1) the thioredoxin/peroxiredoxin antioxidant
system protects b-cells from reactive oxygen and nitrogen species; 2) nitric oxide, in a b-cell selective manner,
attenuates DNA damage response (DDR) signaling by inhibiting mitochondrial oxidative metabolism and
decreasing the levels ATP and NAD levels; and 3) IL-1 signaling promotes an adaptive protective response in
endocrine cells. A number of biochemical, molecular, immunological, cell biological, and transgenic techniques
will be utilized to investigate the cellular pathways through which nitric oxide and its reactive intermediates
participate in the protection of β-cells from damage. It is hoped that insights into the mechanisms controlling the
protective responses activated in β-cells following cytokine stimulation that are gained from these studies will
influence the design of therapeutic strategies aimed to activate protective pathways in b-cell as a mechanism to
limit the loss of function β-cell mass during the development of diabetes or recurrence of diabetes in the
transplantation setting.

Public health relevance
Project Narrative Autoimmune, or insulin-dependent diabetes mellitus, is characterized by an inflammatory reaction in and around pancreatic islets, followed by selective destruction of b-cells. Soluble mediators known as cytokines are believed to contribute to b-cell damage during this process. We have recently uncovered a number of protective responses that are activated by cytokines and the long range goals of this work are to identify potential thearputic potential of these b-cell protective pathways in an effort to treat or prevent autoimmune diabetes.